Core C - Biospecimans and Bioinformatics Core

Project Summary/Abstract
In the prior funding period, the Biospecimen and Bioinformatics Core (Core C) was extremely productive in its
development of new methods and provision of an essential core resource for the processing, storage, and
distribution of biospecimens collected from the clinical studies and advanced Bioinformatics support for “Type 2
inflammatory phenotyping” and genomic analyses. In this funding period, the Biospecimen and Bioinformatics
Core will continue to provide essential processing, storage, and distribution of biospecimens collected from the
clinical studies funded by this grant and will refine mass cytometry (CyTOF protocols) and perform new services
related to mass cytometry (CyTOF). These CyTOF services include development and validation of CyTOF
panels and CyTOF staining of the experimental samples. The Core’s Bioinformatics resource also has optimized
pipelines for handling the new data analysis challenges related to CyTOF and will provide specialized cross-
investigator integrated analyses of bulk RNA-seq, single cell sequencing, ATAC-seq and DNA methylation
studies proposed in the projects. Core C will integrate these analyses using scientific input from all 3 projects
and perform iterative analyses across experiments and experimental groups. Finally, this core will share banked
samples from the IRB-approved existing UCSF Airway Tissue Bank to the Projects of this P01. The
Bioinformatics Core will have an extension at National Jewish Health led by Max A. Seibold, who is also a Co-I
for Project 3. It will also have expert input on CyTOF from Dr. Matthew Spitzer (a Co-I on the Core) and expert
input on single cell RNA-seq analyses from Dr. David Erle (a consultant/collaborator).

Public health relevance
Project Narrative The proposed research is relevant to public health because asthma is a common medical condition, severe asthma accounts for great public health burden and cost, and further advancing effective treatment of severe asthma will depend on identifying the biological mechanisms underlying the persistence of type 2 inflammation in the airway. Successful completion of the work proposed in this Core will provide each of the associated projects with the clinical samples, perform advanced cell staining protocols (CyTOF) and provide advanced biostatistical support for genomics analyses.